LIFR-alpha/JAK/STAT3-dependent Adipose Inflammation Contributes to Obesity-Associated NAFLD - Resubmissi

ABSTRACT
Although adipose inflammation is associated with obesity, its role in reprogramming adipocytes and other cells
in adipose towards the development of obesity’s metabolic comorbidities including steatosis remain unclear. The
complex intracellular (stromal, vascular, immune, and adipocyte) interactions within adipose tissue ultimately
regulate its size by balancing adipocyte triacylglyceride (TAG) lipolysis and synthesis. The inflammatory signaling
of and between these cell types may also influence adipocyte responses to cAMP modulators. To understand
the convergence of these interactions, we previously identified cytokine leukemia inhibitory factor (LIF) as a
secretory molecule that increased adipose inflammation and lipolysis. Wild type mice on a high fat diet (HFD)
demonstrated 7-fold higher LIF and IL-6 adipose mRNA than matched animals on normal diets. When
recombinant LIF was administered to wild-type mice, it caused >50% loss of fat mass through JAK/STAT3-
dependent reprogramming of adipose tissue, increasing lipolysis and amplifying inflammation by altering the
expression of other cyto/adipokines. JAK inhibitor treatment of rLIF-administered mice suppressed adipose loss
through 1) inhibition of adipose inflammation as determined by decreased STAT3 phosphorylation, 2) decreased
adipocyte lipolysis, and 3) inhibition of cyto/adipokine changes. To establish the importance of this signaling
pathway to adipose inflammation, we selectively silenced LIF receptor (LIFR-α, gene LIFR) or STAT3 in
adipocytes and assessed murine development in diet-induced obesity. Both models had decreased adipose
inflammation resulting in a 50% increase in adipose mass and a ~75% reduction in total hepatic TAG levels
compared to controls, limiting non-alcoholic fatty liver disease (NAFLD) and steatohepatitis in these mice.
Conversely, with adipocyte silencing of the JAK/STAT counter-regulator SOCS3 in mice on HFDs, we observed
the opposite phenotype with a ~30% reduction in adipose mass compared to controls. We hypothesize that a
LIFR-α/JAK/STAT3-dependent Cytokine-Adipose-Hepatic Axis facilitates adipose inflammation, leading to
increased lipolysis and altered expression of other cyto/adipokines. The activation of this axis limits adipose
expansion, resulting in TAG mobilization from adipose to the liver and ultimately contributing to
NAFLD/steatohepatitis. This inflammatory-driven axis also affects adipose responses to systemic metabolic
change, sensitizing adipocytes to lipolytic regulation by other cAMP modulators. Finally, we present preliminary
data that the IL-6 family of cytokines signal through JAK/STAT3 inducing the expression of adenylyl cyclase 5
(ADCY5) to reprogram adipocytes in regulating lipid mobilization. SA1 will evaluate the contribution of the LIFR-α/JAK/STAT3 signaling cascade in adipocytes to the Cytokine-Adipose-Hepatic Axis. SA2 will use a genetics-based approach to verify that cytokine-mediated reprogramming of adipocytes in promoting lipid mobilization
requires ADCY5 function. SA3 will use single cell RNA-Seq techniques in our multiple mouse models to identify
non-adipocyte contributors to inflammation-regulated obesity and NAFLD.

Public health relevance
SUMMARY Although adipose inflammation is associated with obesity, the defined pathways and their role in the development of the metabolic sequelae of obesity including non-alcoholic fatty liver disease (NAFLD) remain unclear. Our studies will determine the cellular and molecular contributors to a novel LIFR-α/JAK/STAT3-dependent Cytokine-Adipose-Hepatic Axis that facilitates adipose inflammation resulting in increased lipolysis and altered expression of other inflammatory/metabolic cyto/adipokines in diet-induced obesity. The activation of this axis limits adipose expansion, resulting in triacylglyceride mobilization from adipose to the liver and ultimately leading to NAFLD and steatohepatitis.